Epitranscriptomic Regulation of Microglia in Alzheimer's Disease

Project Summary
Alzheimer’s disease (AD) is a progressive neurodegenerative disorder characterized by memory loss and
cognitive impairment which constitutes the most common type of dementia and impacts nearly 6 million people
in the US. AD has a complex etiology which includes genetic contributions, environmental factors, and age-
associated changes in the brain. In addition, brain inflammation has emerged as a key factor in the development
and progression of AD. Thus, understanding the brain’s inflammatory response is critical for comprehending the
factors that contribute to AD as well as for identifying biomarkers and novel therapeutic targets. Within the brain,
microglial cells are the major cell type that mediate the response to neuroinflammation. These cells normally
exist in a resting state but then become activated in response to inflammatory stimuli. At early stages of disease,
microglial activation plays a beneficial role by releasing anti-inflammatory cytokines and contributing to the
clearance of pathogenic protein aggregates that accumulate in the AD brain. However, prolonged microglial
activation causes the release of neurotoxic factors and excessive synaptic pruning, promoting disease
progression. Thus, understanding the factors that control the transition from a resting to an active microglial state
and elucidating how microglial function is regulated during AD pathogenesis is crucial for determining how this
critical cell type contributes to disease, as well as for developing novel microglial-targeting therapeutics. One
mechanism that the brain uses to control gene expression is methylation of adenosine residues in mRNA to form
m6A. The m6A modification is found in thousands of transcripts and enables fine-tuning of gene expression in
response to a variety of stimuli and cellular states. In addition, m6A and its regulatory proteins are altered in the
brains of AD patients. Here, we will explore the hypothesis that dynamic regulation of m6A contributes to gene
expression changes that underlie microglial cell activation in response to inflammation. Using new technologies
developed in our lab, we will identify for the first time the m6A sites that undergo dynamic methylation in microglia
during AD progression (Aim 1). Then, we will uncover the proteins in microglia that bind to m6A and investigate
how microglial activation alters RNA:protein interactions (Aim 2). Finally, we will determine how microglial-
specific depletion of m6A contributes to microglial function and AD progression using a novel mouse model (Aim
3). Altogether, these studies will be the first to explore m6A dynamics in microglial cells in vivo during AD and will
provide new knowledge of the role of m6A in microglial activation and AD progression.

Public health relevance
Project Narrative Brain inflammation is a contributing factor to Alzheimer’s disease (AD), and microglial cells are the primary cell type that mediates the brain’s inflammatory response. Microglia are a critical cell type during AD progression, but the factors that regulate microglial cell function during AD are poorly understood. Here, we will investigate the role of the widespread mRNA modification m6A in microglial cell responses to inflammation during AD and elucidate the mechanisms of m6A-dependent gene expression control in microglia, paving the way for biomarker discovery as well as identification of novel therapeutic targets.